Investigation of the spontaneous circadian hamster mutation Theta

DESCRIPTION (provided by applicant): A cell autonomous molecular clock temporally organizes many essential physiological functions. Disruption of the clock thus has numerous consequences for health. Forward genetic screens have identified multiple clock components and the core principles of the clock are highly conserved. Recently, our collaborator discovered a golden hamster (Mesocricetus auratus) with a spontaneous mutation (Theta) that results in a dramatic elongation of the hamster's endogenous period. The focus of this proposal will be to elucidate how this mutation disrupts known relationships between core clock genes and, eventually, to identify the mutation in the hamster genome. I will look at mRNA and protein expression dynamics in tissue to identify alterations in the relationships between known clock genes. To determine whether period elongation is a cell autonomous feature of the Theta clock, I will use cell-based real time luminescence reporters in primary fibroblast cultures. Finally, using whole genome sequencing and bulk segregation analysis, I will identify a candidate region in the hamster genome and narrow the field of variants through cellular assays until the causative mutation has been determined. Ultimately, Theta will provide insight into the mechanisms governing the correct timing of the endogenous clock.

Public health relevance
PUBLIC HEALTH RELEVANCE: The advent of electric light has led increasingly to disruption of natural timing systems in our population with downstream effects on metabolism, immune function, and mood, amongst other things. Identifying key components of this molecular clock and the relationships between these components will help to deepen our understanding of the temporal organization of physiology. This proposal focuses on a recently discovered spontaneous mutation (Theta) in the golden hamster (Mesocricetus auratus) that dramatically elongates the hamster's endogenous period, suggesting that Theta is a critical component of normal clock function. Using whole genome sequencing and techniques to identify genomic regions of conserved descent, we will identify this mutation and seek to elucidate the role of Theta as a component in the molecular clock.